Alcohol/Stress Effects on Kappa Opioid Receptors in the Amygdala and Accumbens

SUMMARY
Stress is a well-known factor in promoting heavy drinking and relapse to drinking in individuals with alcohol use
disorder (AUD), and avoidance of the negative affective symptoms of ethanol withdrawal (e.g. anxiety and
depression) is also believed to play a critical role in relapse. Further, disorders of negative affect may
predispose individuals to AUD and the interaction of these disorders may exacerbate symptoms of both. One
component of the brain stress system is comprised of the neuropeptide dynorphin and its target, the kappa
opioid receptors (KOR), and it is augmented following exposure to chronic alcohol and/or stress. We will use a
mouse model of chronic intermittent ethanol (CIE) exposure combined with either chronic forced swim stress or
mouse single prolonged stress to understand the role that KORs play in the maladaptive neurobiological
changes induced by stress/ethanol interactions. Our previous work revealed that the function of the
dynorphin/KOR system in the nucleus accumbens (NAc) was robustly up-regulated by chronic ethanol
exposure and withdrawal in a time/exposure dependent manner in both the CIE model in mice and in a long-
term voluntary ethanol drinking model in monkeys. In addition, in mice we found that systemic administration of
a KOR antagonist reduced anxiety/compulsive behaviors (marble burying) and withdrawal-induced excessive
drinking. Dopamine (DA) is involved in negative affective responses to stress, and DA terminals are known
targets of KOR activity. Therefore, we will use a multipronged approach to examine KOR regulation of DA
signaling in the NAc, which regulates motivation to drink alcohol, and the basolateral amygdala (BLA), which
regulates stress/anxiety-related behaviors, using conditional viral knockdown of KORs from these regions,
microdialysis to assess basal dopamine and dynorphin levels following exposure to CIE and/or stress
paradigms, and the fluorescent sensor dLight to query real-time dopamine signaling in these animals in
response to time-locked behaviors. The overall goal of this proposal is to define the role of KORs on DA
signaling in the NAc and BLA following exposure to chronic alcohol and/or stress, and how these adaptations
in stress-responsive limbic circuitry nodes that are responsible for withdrawal-associated negative affect can
be targeted for the treatment of AUD.

Public health relevance
Alcohol use disorder (AUD) is a crippling condition that impacts approximately 1 in 12 Americans, and exposure to stress has been demonstrated to both increase vulnerability to developing AUD as well as worsen AUD in those already suffering. Brain stress systems, such as the dynorphin/kappa opioid receptor (Dyn/KOR) system, have been implicated in neurological adaptations to stress and/or alcohol exposure which drive negative behavioral states. In this proposal, we examine how KORs adapt in various brain regions associated with alcohol and stress in response to chronic dependency-like alcohol exposure and a two stress paradigms in mice, in the hopes that our results will help guide pharmacological treatment of both AUD and negative affect conditions.